IDENTIFICATION OF PHOSPHOLIPID-DEPENDENT PROTEIN KINASE

Protein phosphorylation constitutes the major mechanism by which extracellular hormones and growth factors modulate intracellular events. The aims of this application comprise studies to pursue the regulation and function of a newly recognized phospholipid-, diolein-dependent protein phosphorylation activity which is independent of Ca2+ and is prominent in a number of estrogen-responsive tissues including rabbit and rat corpora lutea (CL), rabbit endometrium, and human breast cancer MCF-7 cells. In rabbit CL, a Mr=76,000 protein (p76) is phosphorylated by this kinase, and phosphorylation of p76 is increased by estradiol. Phosphorylation of p76 represents autophosphorylation by this kinase. We have named the phospholipid-, diolein-dependent, Ca2+-independent kinase which is autophosphorylated and exhibits a Mr=76,000 in rabbit CL p76 C-kinase. We propose to evaluate p76 C-kinase, determining its biochemical properties, its subcellular localization, its hormonal regulation, and its amino acid sequence. Specific aims are: (1) To purify and characterize biochemically p76 C-kinase; (2) To determine the amino acid sequence of p76 C-kinase by isolating the cDNA encoding this protein from a rabbit luteal cDNA library and sequencing it and to produce antibodies to a unique peptide fragment of p76 C-kinase; (3) To identify structural features of p76 C-kinase, based on its amino acid sequence, that are important for its regulation; (4) To evaluate the subcellular distribution of p76 C-kinase and to determine if in vivo hormone administration promotes redistribution of p76 C-kinase; and (5) To evaluate the hormonal/growth factor regulation of p76 C-kinase activity, protein and mRNA in vivo and in vitro.